Impact of Local vs. Systemic Senescent Bone Cell Accumulation on Healthy Osteocyte Mechanosensation

PROJECT SUMMARY / ABSTRACT
The goals of this proposal are to: (1) acquire the experimental skills and career training necessary to expand my
research program into cellular aging/senescence and molecular biology, (2) investigate how the accumulation of
senescent cells (SnCs) and their senescence-associated secretory phenotypes (SASPs) impact osteocyte
mechanobiology in a 3D bone-mimicking microenvironment, and (3) generate foundational data to support future
NIH R01 applications. Our previous studies have shown that SnC accumulation with age at various sites has
anti-resorptive and anabolic effects, ultimately leading to bone loss. However, the mechanisms by which local
and systemic SnCs disrupt osteocyte mechanosensation during aging remain unclear. This proposal addresses
three crucial knowledge gaps: (Aim 1) How do local vs. systemic SnCs and SASP influence cytoskeletal stiffness
and membrane viscoelasticity in healthy osteocytes? (Aim 2) How do age-related changes in cytoskeletal
stiffness impact osteocyte responses to mechanical stimuli? (Aim 3) What are the reciprocal effects of
senescence between osteocytes and bone marrow mesenchymal stem cells (BMSCs)? My preliminary data
show that senescent osteocytes exhibit time-dependent increases in cytoskeletal stiffness, with local interactions
between senescent and healthy osteocytes having a greater impact than systemic SASP exposure. Based on
these data, my central hypothesis is that senescent osteocytes impair healthy osteocyte mechanosensation
through cytoskeletal stiffening, with local and systemic interactions differentially impacting healthy osteocytes.
To test this, I will develop novel 2D and 3D co-culture models using our visible light-induced 3D bioprinting
technique and biocompatible hydrogel-based bio-inks to mimic the bone microenvironment. These models will
allow investigation into how SnCs within the bone microenvironment, both locally and systemically, affect
osteocyte mechanobiology and mechanosensation. Micromechanical properties of osteocytes and their
surrounding matrix will be measured using optical fiber-based interferometry nanoindentation coupled with live-
cell immunofluorescence staining. These biophysical measurements will be correlated with gene and protein
expression analyses to mechanistically determine the impact of SnCs in the bone microenvironment on
osteocyte mechanobiology. The successful completion of these aims will provide critical mechanistic insights
into how bone mechanobiology is altered by aging and cellular senescence, supporting the development of
therapeutic strategies to rejuvenate or eliminate SnCs to restore osteocyte function. The proposed training plan
integrates advanced techniques in cellular senescence and biomolecular assays, with opportunities to extend
into transgenic mouse models, which will support my future research projects and R01 applications.

Public health relevance
PROJECT NARRATIVE This project investigates how local and systemic accumulation of senescent cells (SnCs) impairs osteocyte mechanobiology within the aging bone microenvironment. By elucidating the specific mechanisms through which SnCs disrupt the mechanobiology of healthy osteocytes and bone homeostasis, this research will pave the way for therapeutic strategies aimed at restoring osteocyte function to combat age-related bone loss. The training provided through this award will also equip me with advanced experimental skills in cellular senescence, enabling me to extend this research into future R01 projects focused on innovative treatments for skeletal aging.